Immobilized phosphate receptors for the treatment of hyperphosphatemia

Hyperphosphatemia, a condition that occurs when the phosphate concentration in serum exceeds 1.46 mM, is
common among patients with advanced chronic and acute kidney disease (CKD) and kidney failure.
Maintenance hemodialysis does not remove phosphate from blood; thus, almost all patients on maintenance
hemodialysis have hyperphosphatemia. Current treatment relies primarily on dietary restrictions and the
administration of oral phosphate binders with food or drink which are often insufficient to manage
hyperphosphatemia for individuals on dialysis. This inability to manage the disorder increases morbidity, mostly
due to cardiovascular events related to vascular and soft tissue calcification. The overarching goal of this project
is to develop, optimize, and translate to the clinic novel affinity columns for normalizing the levels of inorganic
phosphate from blood quickly, safely, and selectively. Our central hypothesis is that we can achieve our goal
using lanthanide complexes conjugated to dendritic polypeptides. Strong preliminary results from our group
indicate that lanthanide complexes with open coordination sites can be designed to bind phosphate directly from
serum and blood with high affinity and selectively over other endogenous ions that are present in much higher
concentrations in serum. These lanthanide complexes are highly stable and do not leach metal in serum or when
bound to phosphate, working as effective `phosphate sponges'. Importantly, the affinity of these complexes for
phosphate can be tuned at will so as to achieve normal serum levels without risking hypophosphatemia. We will
further develop, optimize, and evaluate a prototype affinity column for the removal of phosphate from blood. The
overall objective of this application is to synthesize a new family of lanthanide complexes that have an
appropriate affinity for phosphate and high selectivity over endogenous ions and to conjugate them onto dendritic
polypeptides The rationale for the proposed research is that lanthanide complexes immobilized on affinity
columns will enable the efficient and rapid removal of excess phosphate from blood without affecting the balance
of other endogenous anions such as bicarbonate. Used in conjunction with dialysis, these phosphate affinity
hemodialysis columns will enable efficient management of hyperphosphatemia. We plan to accomplish our
objectives by pursuing the following Specific Aims: 1) Develop novel metal complexes for the selective
sequestration of phosphate from serum; 2) Synthesize and characterize lanthanide receptors supported on
dendritic polypeptides and evaluate their ability to balance phosphate levels in serum; and 3) Evaluate the ability
of receptor-immobilized affinity columns to normalize blood phosphate levels ex vivo and in vivo during
hemodialysis. Our research is significant because it aims to develop a new technology to efficiently and safely
treat hyperphosphatemia in patients with CKD and renal failure. This will improve dialysis patient outcome and
quality of life. Our research is innovative because it will develop the first affinity columns utilizing lanthanide
complexes grafted onto dendritic polypeptides for balancing phosphate levels in blood.

Public health relevance
Narrative The proposed research is relevant to public health because it will provide new materials and technology to treat hyperphosphatemia. Hyperphosphatemia is common among patients with advanced chronic kidney disease and kidney failure and is not efficiently treated with dialysis and oral phosphate binders. The properties of the complexes and the materials will be optimized to ensure their safety and efficacy in blood.